Tissue Engineering Resource Center: TR&D2

SUMMARY
TR&D2 will continue to focus on the development of imaging enabled micro-scale bioreactors with optical
control and sensing and spatiotemporal visualization of biological events. These systems, containing one or
more tissues, are often called “organs-on-chip” because of their ability to recapitulate organ level functions,
such as liver metabolism or contractile function of the heart. Because of this ability to model human physiology
and disease, they overcome many of the limitations of current cell and animal models and are being considered
a fast-track opportunity for tissue engineering to advance drug development and precision medicine. In current
TERC, we have developed bioreactors with optical control and sensing and spatiotemporal visualization of
biological events, such as optogenetic control of cell differentiation to engineer stratified tissues. We also
established ability to maintain each tissue in its optimal niche while linking them to each other by vascular flow
to allow cross-talk. TERC renewal will leverage these advances to develop a cohesive approach to the design
of deployable imaging-enabled micro-scale bioreactors for broad use. As in current TERC, all tissues will be
derived from iPSCs, to allow patient specific and precision medicine studies. To advance biological fidelity of
these human tissue models, we will incorporate a bone marrow module to provide sustained supply of immune
cells, which play major roles in many diseases. In Aim 1, we will establish a configurable plug-and-play platform
with several different modalities for real-time imaging and feedback control, as a foundational technology for
studying human pathophysiology, in the context of both individual organ studies (TR&D2 Aim 2 and Aim 3) and
systemic conditions (TR&D3 Aim 2). To demonstrate broad utility for studies of disease, injury and regeneration,
we will address two major challenges in the field: generation of electromechanically active tissues (Aim 2:
cardiac -bone marrow bioreactor) and appropriate zoning and responses to physiologic loads (Aim 3: synovial
joint – bone marrow bioreactor).